Defining the role of Serratia marcescens nuclease in infection process

Project Summary
The emergence of bacterial drug resistance, especially in hospital settings, represents the next
great challenge in healthcare. Serratia marcescens, the Gram-negative bacterial pathogen with
intrinsic resistance to several classes of antibiotics, can cause infections with severe outcomes
affecting multiple body sites. This bacterium is also associated with complications of peritoneal
dialysis (PD) in patients with kidney failure. Importantly, Serratia-associated peritonitis
accompanied by massive neutrophil infiltration was shown to have the highest nonresolution rate
among episodes caused by Gram-negative bacteria, leading either to the death of the PD patient,
or catheter removal and transfer to hemodialysis. The progress in our understanding of S.
marcescens infections is hampered by the lack of reliable preclinical model, which represents a
critical barrier to progress in the field. The current knowledge of strategies used by this
opportunistic pathogen to colonize the mammalian host and to evade the immune response is not
complete, and only a handful of virulence factors were identified to date. S. marcescens is known
to secrete an array of hydrolytic enzymes, including sugar non-specific endonuclease; however,
the biological role of this enzyme during infection has not been evaluated. In this proposal, we
seek to establish a murine model to study the S. marcescens dynamic spread during
intraperitoneal infection and to test a hypothesis that an extracellular S. marcescens enzyme
nuclease plays a key role in bacterial escape from neutrophil extracellular traps (NETs) in this
niche. In Aim 1 we will characterize the bioluminescent S. marcescens spread following
intraperitoneal infection using in vivo imaging. In Aim 2 we will first evaluate the S. marcescens
extracellular nuclease potential to degrade NETs in cultures of neutrophil-like cells, followed by
infection study to determine the biological role of this enzyme in vivo. This proposal will advance
current understanding of Serratia pathogenesis and provide insight into the bacterium’s strategy
to avoid neutrophil-mediated clearance. Altogether, our experiments will establish a blueprint for
future studies of other nuclease-producing pathogenic bacteria.

Public health relevance
Project Narrative The alarming potential for deadly systemic infections, and the high prevalence of multi-drug resistant Serratia marcescens in hospital settings drive the need to identify additional targets for bacterial growth inhibition, which is currently impeded by the lack of reliable animal models. The proposed study will uncover novel details on the spatiotemporal spread of S. marcescens following intraperitoneal infection and will unveil a biological role for the extracellular nuclease produced by this organism during infection. This project will also chart a unified approach for the detailed analysis of other bacterial pathogens with secreted nucleases.